The Logic of Aptamer Isolation

Summary
My goal in this collection of projects is to establish a unified framework to generate oligonucleotide-based
receptors (aptamers) for small molecules based on concepts from organic and medicinal chemistry, with the
focus on those targets that are otherwise difficult to isolate through standard protocols. In the process, I will
generate a practical understanding of relationships between the complexity of the interactions in receptor space
and the chemical forces (packing) that define this complexity, and build algorithms that can help us to access
new properties, with possible applications beyond the aptamer isolation. These receptors will then enable rapid
quantification, frequent monitoring, and multiplexing of challenging clinical analytes in complex mixtures.
The experimental work in this program will specifically address the following two questions:
1. Can DNA receptors serve as general, off-the-shelf parts for biosensors and their arrays, interacting even
with anions, small polar molecules, and, at the other extreme, hydrophobic molecules with complex shapes?
2. What are broadly applicable heuristics (suitable levels of abstraction) that could guide isolation of these
receptors from the vast space of random oligonucleotides, when standard methods fail?
The first question has direct, broad implications for our ability to use of the aptameric receptors in monitoring
human health. It can be answered only empirically, by isolating receptors for difficult and disparate targets,
ranging from phosphate, a small anion, to cyclosporine A, a poorly soluble, non-planar, immunosuppressant
drug. Traditionally, the failures to isolate aptamers for such targets were explained by mismatches with functional
groups on DNA; in contrast, I will pursue this as a problem of a combinatorial difficulty. All isolated receptors will
be subsequently validated, within sensing devices, against gold-standard methods and in relevant matrices.
The second question is then an approach to address a reformulated big challenge of finding macromolecules
with complex functions in populations of random oligomers. This is a problem that has no direct optimal solutions,
because of the combinatorial explosion of all possible species. Instead, we will use our understanding of general
principles of ligand-receptor interactions to develop simple rules, which will be akin to individual steps in organic
synthesis. When combined, they will allow us to implement multi-step procedures to isolate very rare functional
oligonucleotide sequences. We have the option to keep adding new rules, while constantly validating the
emerging heuristics empirically, through a series of practical implementations while pursuing the first question.
Indeed, our principal practical goal, and the main criterion for success, will be to present multiple examples of
tailored isolation procedures that would lead to identification of clinically useful DNA receptors with complexities
that would otherwise bar their isolations in traditional single-step protocols.

Public health relevance
Narrative Oligonucleotide-based receptors, aptamers, have potential to serve as general recognition modules for biosensing devices, yet their broad use is prevented by our inability to isolate the structurally complex aptamers that are required to target whole classes of low molecular weight ligands. We will design multistep protocols to overcome probabilistic barriers that prevent isolation of complex receptors from vast libraries of random oligonucleotides. Once isolated and optimized, these receptors for ligands such as small, highly polar anions, and large, very hydrophobic, almost insoluble macrolides, will be used to address critical medical needs.